Molecular Regulation of Photoreceptor Cell Death

ABSTRACT
Retinal diseases are a leading cause of blindness, tremendously impacting patients and society. A root
cause of poor vision is death of the photoreceptor cell, which primarily results from disruption of the normal
homeostatic interaction between these cells and the underlying retinal pigment epithelium (RPE). Preserving
photoreceptor (PR) viability and function remains a critical unmet medical need. PRs have the highest oxygen
consumption in the body. The choroidal vasculature supplies this demand through the RPE – a process that
requires close apposition and intimate interaction. Periods of disrupted retina-RPE homeostasis might be
expected to result in marked and rapid PR cell death. However, PRs can survive periods of reduced RPE
nutritional support, resulting in a clinical window of opportunity for treating retinal disease. Currently there are
no therapeutic options to maintain PR viability or slow the rate of cell death to extend this treatment window. In
experimental retinal detachments (RD), a validated model of altered PR-RPE homeostasis, we have found
activation of both pro-survival and death pathways. Examples of the former include the release of protective
cytokines and activation of autophagy; whereas cell death occurs primarily through Fas-mediated apoptosis. A
major gap in our knowledge is that we do not know the upstream activators of these cytoprotective and
cytodestructive pathways. We hypothesize that HMGB1 and microglia represent key intrinsic and extrinsic
influences, respectively. Our preliminary data strongly point towards a role for the multifunction protein known
as High-Mobility Group Box 1 (HMGB1) in the intrinsic protection of PR and the innate immune response to
stressed PR. In Specific Aim 1 we will define the role of HMGB1 in PR death and activation of retinal microglia
after RD and in a model of inherited retinal degeneration. Our preliminary data connects the upregulation of
HMGB1 in rod PR to protective autophagy and the activation of microglia following RD. We will investigate the
function of cytosolic HMGB1 in cell-autonomous activation and stabilization of pro-survival pathways within
PRs and the function of released HMGB1 to promote microglial activation. In Specific Aim 2 we will determine
the role of microglia in the inflammatory response and PR death following RD. The relative contributions of
microglia and infiltrating myeloid leukocytes and how the immune response affects PR survival are not clear.
Based on our preliminary data, we hypothesize that resident microglia are the major first responders to RD,
and that microglia are initially protective but eventually shift to a detrimental inflammatory phenotype. We
further hypothesize that the p38a-ULK1 axis contributes to this shift. We will define and characterize the
immune cells responding to RD and test if targeting p38a and promoting autophagy are protective following
RD. The work proposed in this grant will provide a critical understanding of the mechanisms regulating the
control of photoreceptor cell survival. It is only through the delineation of these fundamental processes that we
will be able to develop targeted therapies to keep these cells alive and improve patient outcomes.

Public health relevance
NARRATIVE Photoreceptor cell death is the root cause of vision loss in many forms of retinal disease, and much of this death derives from the disruption of normal photoreceptor homeostasis and inflammation. The mechanisms that control the balance between pro-survival and pro-death influences are not well understood. In this project we will explore the intrinsic pro-survival pathways activated within the stressed photoreceptor and the innate immune responses that can cause inflammation and photoreceptor death.